Identify the DNA Adduct and Associated Metabolic Alterations in Bladder Cancer of Smokers

Project Summary/Abstract
Smoking is a major risk factor for bladder cancer (BCa). Patients with current or past history of smoking have a
three times higher likelihood of developing BCa. Smoking is also known to have a potential dose-dependent
effect on the grade and stage of BCa, with high-dose smokers having more aggressive disease. In addition,
smokers with BCa have a higher likelihood of failing chemotherapy. Currently, markers that can stratify
smokers based on their risk of developing BCa are lacking. Furthermore, predictive markers for aggressive
BCa among high-dose smokers are also lacking. The central goal of this application is to characterize the
DNA adducts and biochemical alterations observed in smoking-associated BCa and use this information to
develop metabolite-based predictive markers and therapeutic strategies for this deadly disease. Cigarette
smoke contains a number of xenobiotic compounds that include arylamines, methylated metabolites, Nicotine-
derived nitrosamine ketone (NNK), Benzo[a]pyrene (BaP), nicotine etc which are usually metabolized by the
xenobiotic metabolism and excreted in the urine. Our strong preliminary data demonstrates altered DNA
adducts and reprogramming of xenobiotic metabolism in BCa smokers. This effect is exaggerated by
components of cigarette smoke including nicotine. Using a novel metabolomics approach, we had earlier
shown that BCa was associated with a unique metabolic signature. From the patients perspective it is
important to be able to measure these markers non-invasively in body fluids like urine. Intriguingly, metabolites
are the end products of overall cellular metabolism. These are small molecules that could be easily monitored
in body fluids to interrogate disease phenotype in question. Quiet provocatively, our group is being established
to utilize metabolites to further monitor tumors. Thus, our current proposal aims to identify DNA adducts and
associated metabolites in BCa smokers and use the information to develop markers for early identification of
patients who are at risk for developing aggressive bladder cancer. Further will enable clinicians to take an
informed decision about more appropriate therapeutic strategies towards personalized medicine.

Public health relevance
Project Narrative This proposal expects to develop a panel of DNA adducts and associated metabolic markers in tissues and urine. The study is supported by a seminal publication highlighting the ability of the PI to develop urine-based metabolic markers for bladder cancer smoker by: 1. utilizing urine based metabolites as non-invasive biomarkers; and, 2. developing smoke associated perturbed metabolic pathways specific to bladder cancer that could be further harnessed to develop better treatment strategies or combinatorial therapy with the existing drugs to overcome smoke induced chemo-resistance. Overall, this proposal is expected to delineate a DNA adducts and associated metabolites with smoke in BCa and develop a first-generation panel of metabolic markers in urine of BCa patients.